Osteoimmunology of Retarded Bone Regeneration in Periodontitis

Retarded bone regeneration is characteristic to periodontitis. Even after successful conventional periodontal
treatment, periodontal bone regeneration rarely, if ever, occurs, while molecular mechanism underlying
retarded bone regeneration is largely unknown. This RO1 application proposes to exploit the
osteoimmunological roles of osteoclast (OC)-specific cell membrane receptor, Osteoclast Stimulatory
Transmembrane Protein (OCSTAMP) and Dendritic Cell-Specific Transmembrane Protein (DC-STAMP) in
retarded bone regeneration in periodontitis. During osteoclastic bone resorption, osteoblast (OB)-activation
molecules, such as insulin-like growth factor (IGF), act as “coupling” factors released from demineralized bone
matrix to ensure that the same amount of bone resorbed by OC is replaced by differentiation and activity of
OB. Strong evidence suggests that this coupling mechanism is interrupted (‘uncoupled’) in periodontitis where
pathogenic bone resorption exceeds reparative bone formation, resulting in retardation of bone regeneration.
Our preliminary results showed that P. gingivalis may be engaged in retarded bone regeneration in
periodontitis. A recent study reported that Semaphorin4D (Sema4D) produced by OC inhibits IGF-mediated
osteogenesis by OB. The upstream molecular event(s) that induce(s)/upregulate(s) Sema4D expression by
RANKL-activated osteoclast precursors (OCp), as well as the mechanism of Sema4D action on OB in the
context of periodontitis, are unknown. We preliminary identify the ligand for OCSTAMP is produced by
activated OCp, and the binding of this ligand with OCSTAMP elicits signals for Sema4D-expression.
Furthermore, periodontal pathogen, P. gingivalis, appears to upregulate the Sema4D production from OCp by
upregulating the generation of OCSTAMP ligand. Based on these preliminary findings and published evidence,
we hypothesized that pathogenic activation of OCSTAMP by its ligand upregulate the production of Sema4D
form OCp which, in turn, inhibits osteogenesis in periodontitis. To test our hypothesis, the following two
Specific Aims are proposed. Aim 1: To elucidate the molecular mechanism underlying the generation of ligand
for OC-STAMP, Aim 2: To assess the impact of OC-STAMP-activation on retarded bone regeneration in a
mouse model of periodontitis induced by the combination of ligature attachment and P. gingivalis infection.
This study will, for the first time, elucidate the pathologic osteoimmunological mechanism that interrupts new
bone formation in alveolar bone affected by periodontitis, thus, representing a potential paradigm shift in the
development of novel periodontitis therapies.

Public health relevance
Project narrative: One out of every two American adults aged 30 and over has periodontitis, which is an inflammatory bone lytic disease caused by poly-microbial infection around tooth. It is well documented that bone regeneration hardly ever occurs at the alveolar bone affected by periodontitis, even after the successful conventional periodontal treatment. Based on our preliminarily discovered finding, i.e., OC-STAMP molecule that specifically expressed by osteoclasts (bone resorbing cells) is engaged in not only bone resorption but also interruption of new bone regeneration, in the proposed RO1 project, we will gain more scientific insight into this finding for the development of novel non-invasive bone regenerative therapy for periodontitis and other bone lytic disease.